Targeting tumor innate immune signaling in pancreatic cancer

PROJECT SUMMARY
Effective treatment remains an unmet and urgent need for patients with pancreatic ductal
adenocarcinoma (PDAC). Unlike most cancer types where targeted therapies and immunotherapy have
become standard treatments, PDAC is unique among major cancers in still relying almost entirely on
chemotherapy for disease control. The administration of multiple cytotoxic agents, while necessary for
efficacy, results in significant clinical toxicities, and treatment response rates remain low at 30–40%, with
responses often lacking durability. Therefore, achieving therapeutic breakthroughs necessitates novel
biological discoveries in pancreatic cancer.
Over the past decade, our lab has generated substantial preclinical and clinical evidence showing
that innate immune signaling pathways in PDAC cells are critical in establishing an immunosuppressive
tumor microenvironment that inhibits anti-tumor T cell activity. We initially focused on IRAK4, a kinase
regulating Toll-like receptor and IL-1 receptor signaling and demonstrated that targeting IRAK4 enhances
chemotherapy efficacy and may potentiate immunotherapy. This work laid the groundwork for three
clinical trials. Building on these insights, we have identified additional signaling nodes related to IRAK4,
with MAP3K8 (TPL2) emerging as a particularly promising target.
Our preliminary data indicate that TPL2 regulates multiple signaling pathways in PDAC cells,
including the processing of micro(mi)-RNA species that may endow these cells with aggressive and
immunosuppressive phenotypes. We found that targeting TPL2 enhances the efficacy of FOLFIRINOX
chemotherapy and reprograms the tumor microenvironment, potentially enabling checkpoint
immunotherapy to be effective in PDAC. Based on these findings, our team proposes three Aims:
Aim 1: We will investigate the mechanism by which TPL2 controls miRNA processing, particularly
through modulation of AGO2 and AGO3 function. This study will provide one of the few
comprehensive analyses of miRNA's role in PDAC biology. To ensure success, we will collaborate
with an experienced RNA biologist, Dr. Sergej Djunarovic.
Aim 2: We will explore the role of TPL2 in PDAC cells, as well as in myeloid and T cells, using a
conditional TPL2 knockout mouse strain provided by Dr. Andrew Greenberg. These experiments will
elucidate how TPL2 influences PDAC tumor progression and inform immunotherapeutic strategies
tested in Aim 3.
Aim 3: We will evaluate the preclinical efficacy of the TPL2 inhibitor tilpisertib combined with
FOLFIRINOX in 20 patient-derived xenograft models. We will also identify a rational
immunotherapeutic combination to be tested in the immunocompetent genetic (KPPC) mouse model.

Public health relevance
PROJECT NARRATIVE Our proposal seeks to elucidate the mechanisms by which MAP3K8, or TPL2 kinase, influences tumor-intrinsic signaling and the immune microenvironment in pancreatic cancer. We will leverage a novel genetic mouse model, state-of-the-art technologies, and a pharmacological approach to address these questions. Our research aims to uncover the unique biology of TPL2 signaling in both immune and pancreatic cancer cells and rigorously evaluate the efficacy of TPL2 inhibitors in combination with chemotherapy and immunotherapy. Ultimately, our goal is to advance novel therapeutic strategies to the clinic for the benefit of pancreatic cancer patients.